Autonomic Circulatory Control in Patients with HFpEF

PROJECT SUMMARY
Heart failure with preserved ejection fraction (HFpEF) is the fastest growing form of HF and is associated with
high morbidity and mortality. A major problem with HFpEF is severe exercise intolerance that leads to reduced
quality of life. Although impaired cardiac output and marked left ventricle relaxation abnormalities are known to
be present, drug therapies targeting cardiac function do not improve exercise tolerance, quality of life, or survival
in HFpEF patients. Thus, a better characterization of HFpEF patients is warranted both at rest and during
physical activities. Sympathetic overactivity is present in several cardiovascular disease states, and aside from
contributing to high blood pressure (BP), this increase in sympathetic nerve activity (SNA) accelerates the
progression of end organ damage that is independent of any rise in BP. Despite these critical problems, it
remains unknown whether resting sympathetic overactivity is involved in the development and progression of
HFpEF. Likewise, whether impairments in SNA control and resultant changes in the peripheral vasculature in
resting and exercising muscle contribute to the severe exercise intolerance and poor prognosis present in HFpEF
is unknown. We will examine the skeletal muscle metaboreflex, a key neural mechanism for increasing SNA with
exercise. Also, sympathetically mediated vasoconstriction in non-exercising and exercising muscles will be
investigated to determine whether the normal blunting of vasoconstriction in active muscle (i.e., functional
sympatholysis) is impaired in HFpEF. All measures will be performed before and after exercise training regimens
designed to minimize the marked increase in cardiac filling pressure during whole-body exercise known to be
present in HFpEF. Overall, the global objective of Project 3 is to comprehensively investigate sympathetic neural
mechanisms in HFpEF at rest and during exercise to seek an effective therapy for HFpEF patients. Aim 1 will
determine whether HFpEF patients have enhanced SNA at rest, and whether exercise intolerance in HFpEF is
associated with greater sympathetic reactivity and impaired functional sympatholysis. We will perform direct
measures of SNA to skeletal muscle using microneurography, along with duplex Doppler ultrasound measures
of peripheral blood flow, during a series of experimental tests to assess SNA control at rest and during exercise
in patients with and without HFpEF. Aim 2 will determine whether whole-body training or single-leg knee
extension differentially effects resting SNA, sympathetic reactivity, functional sympatholysis, and muscle
metaboreflex activation in HFpEF patients. Patients will be randomly assigned to 16 weeks of either single-leg
knee extension, where the heart is not limiting, or whole-body training with nitroglycerin treatment to attenuate
the rise in cardiac filling pressure (1:1 ratio) with complete sympathetic assessments performed before and after
training. Information gained from this research will lead to a comprehensive understanding of sympathetic neural
mechanisms in patients with HFpEF and will provide important insight into potential therapeutic targets to
improve quality of life and survival in HFpEF patients.

Public health relevance
Heart failure with preserved ejection fraction (HFpEF) is the fastest growing form of heart failure in the US, with severe exercise intolerance being a cornerstone of the disease, leading to reduced quality of life. Although impaired cardiac output and marked relaxation abnormalities of the left ventricle are present, drug therapies targeting cardiac function do not improve exercise tolerance or quality of life in HFpEF patients and therefore, a better characterization of HFpEF patients is needed both at rest and during physical activities. Given the importance of the sympathetic nervous system in maintaining cardiovascular homeostasis and in the cardiovascular adjustments to exercise, we propose a comprehensive assessment of sympathetic neural control mechanisms at rest and during physical activities in HFpEF patients before and after exercise training.